COLONY OF AGED FISCHER 344 RAT STRAINS

The specific objective of this contract is to develop, maintain, and distribute a standing colony of genetically defined Fischer 344 rat strains for use by investigators in the study of aging. The colony is maintained within controlled and defined barrier environments where animals are monitored and characterized for disease status, pathologic, and degenerative changes with age.